EFFECTS OF DILTIAZEM ON BAROREFLEX MECHANISMS IN NORMAL AND HYPERTENSIVE MAN

Comparison of the effects of diltiazem, hydralazine and placebo on forearm blood flow, cardiopulmonary arterial baroreflexes and sympathetic nerve outflow in normals and patients with mild to moderate hypertension.